Regulation of mitotic chromosomes

Project Summary
Proper chromosome segregation during mitosis is fundamental to cell growth and organism development.
Failures in this step lead to developmental diseases, immunodeficiency, and cancers. My research program
aims to reveal molecular mechanisms critical for chromosome segregation and elucidate the consequences of
their failures, which can be exploited to enhance the efficacy of chemotherapeutic treatments.
1) Roles of nucleosome regulators in chromosome segregation: During mitosis, chromosomes dramatically
change their functions and morphology to support their segregation. Chromosomes become condensed, while
promoting formation of mitotic apparatuses, such as kinetochores and spindle microtubules. Although histones
are the most abundant chromatin proteins, the importance of histones in transcriptional regulation makes it
challenging to dissect their direct roles in mitosis. Our lab has established a novel method to manipulate
histones and evaluate their consequences using Xenopus egg extracts, which recapitulates a variety of
chromatin events independently of transcription. We discovered that the chromosomal passenger complex
(CPC) must interact with both nucleosomes and microtubules to support spindle assembly. As chromatin
proteins regulated by the CPC, we discovered a novel nucleosome-remodeling complex composed of HELLS
and CDCA7, relevant to Centromere instability and Facial anomalies (ICF) syndrome. By dissecting the roles
of HELLS-CDCA7 and other nucleosome regulators, we will investigate the poorly understood mechanisms
and functional significance of mitosis-specific control of nucleosome dynamics and functions.
2) Mechanisms that maintain human centromere integrity: Human centromeres, where kinetochores assemble
to capture microtubules, are composed of a long array of repetitive element, α-satellite DNA. We have shown
that α-satellite repetitive arrangement becomes unstable in cancer cells and during cellular senescence, and
that centromere-binding proteins are important for preserving this arrangement. We will dissect mechanisms
that maintain integrity of centromere-associated repetitive elements.
3) Recognition of mitotic failures by the innate immune system: We hypothesize that nucleosomes act as a
hallmark that distinguish between genomic DNAs and foreign or aberrant DNAs. Consistent with this idea, we
demonstrated that the nucleosome competitively binds and inhibits DNA-induced stimulation of the cytoplasmic
DNA sensor, cGAS, a component of the innate immune system. We showed that during extended mitosis,
cGAS is slowly activated and induce cell death. Cells that do not express cGAS are less prone to die during
mitotic arrest induced by taxol, which is frequently used in cancer chemotherapy. Thus, cGAS expression level
could be a predictor of the efficacy of taxol, and cGAS mediated-immunity may affect cytotoxic effect of taxol
on tumors. We will investigate mechanisms behind cGAS-induced cell death and its relevance to clinical
treatment with taxol.

Public health relevance
Project Narrative Failures in chromosome segregation cause cancers, birth defects and immune deficiency. Combining a diverse set of experimental approaches, including imaging, biochemistry and structural analysis, this research program will seek to dissect the mechanism that control structure and functions of mitotic chromosomes. In addition, we will test our hypothesis that the status of the innate immune system that responds to abortive mitosis affects efficacy of taxol, anti-mitotic drug widely used for cancer chemotherapy.